Relationship of Immune Responses to Clinical Phenotype and Familial Risk in Eosinophilic Gastroenteritis

ABSTRACT
Upper Eosinophilic Gastrointestinal Diseases (EGIDs) include Eosinophilic Esophagitis (EoE) and Eosinophilic
Gastroenteritis (EGE, which encompasses Eosinophilic Gastritis, EoG, and Eosinophilic Duodenitis, EoD).
EGE is one of the more rare EGID subtypes which results in significant morbidity in all genders and ages.
Patients with EGE suffer from significant GI symptoms, often mislabeled as irritable bowel syndrome,
abdominal pain, and diarrhea. Due to issues in ascertainment of adequate biopsy tissues and eosinophil
enumeration in biopsies, these diseases often go under-recognized, resulting in significant healthcare and
patient cost. While the etiology of EGE is unknown, we and others have observed that 60-80% of EGE cases
coexist with EoE and the remaining 20-40% are isolated EGE cases. Similar to EoE, EGE likely has different
immune underpinnings potentially reflected by whether the disease manifests as a more diffuse eosinophilic
disease (EGE+EoE) or whether it is isolated eosinophilic disease (EGE). We propose to investigate
immunologic signatures in EGE cases with and without concurrent EoE and determine if these signatures
predict elevated gastrointestinal eosinophil counts in high-risk relatives without a diagnosis of EGE. Certain
tissue-based RNA signatures (especially those related to eosinophil inflammation) may accurately identify and
predict EGE, and thus provide a solution to the under-recognition from poor biopsy protocols and lack of
eosinophil enumeration. We have recently published that EoE increases one’s risk for EGE in self and families.
Identification of relatives of EoE probands with Th2 (or other) mediated inflammation may reflect increased
eosinophilia, identifying missed disease or those who would benefit from further work up with eosinophil
enumeration. This proposal seeks to further understanding of the immunopathology of EGE through study of
those with and without involvement of EoE and associated conditions. This project will aid in the identification
of biomarkers for earlier diagnosis and management of EGE leading to fewer endoscopies and biopsies along
with more personalized disease management.

Public health relevance
PUBLIC HEALTH NARRATIVE Patients with Eosinophilic Gastroenteritis (EGE) suffer for years without a diagnosis or adequate therapy due to lack of understanding of risks and markers for disease. Identification of immune markers reflecting immune underpinnings and phenotypes of disease will improve the identification, comprehension, and diagnosis of the disease. Furthermore, recognition of familial risks for EGE will aid clinicians in their diagnostic path, empowering them to diagnose disease early on, and treat adequately, avoiding increased medical costs and complications of disease.